Understanding hospital value: provider, hospital and community effects

Abstract
Policymakers and payers in the US are now focusing intensively on healthcare value, commonly defined as
quality achieved per dollar spent, as a means of simultaneously improving quality of care and reducing or
stabilizing costs. In 2017, 34% of payments across all payers were through value-based models, while only
41% were through traditional fee-for-service models. Inpatient care accounts for one third of all US health
expenditures and has had the most long-standing value-based models. To date, however, value-based
programs for inpatient care have had mixed or discouraging results. Without a clear understanding of what
factors help hospitals and communities provide high value care, the value-based payment movement may not
succeed. This renewal proposal extends work successfully done in the first funded R01, which explored
hospital and community factors associated with readmission (one specific example of quality and cost). During
that grant, which has already generated 14 publications in journals such as The New England Journal of
Medicine and JAMA and 174 citations, we developed a robust data infrastructure that links 6.8 million
hospitalizations to over 70 hospital and community factors. In this study, we will build upon that data
infrastructure to explore practitioner, hospital and community factors associated with the overall value of
inpatient healthcare. In Aim 1, we will use the Centers for Medicare & Medicaid Services (CMS) Star Ratings
measure developed by our team as our main quality outcome (which aggregates performance on 57 measures
of mortality, readmission, safety, experience, effectiveness, and use of imaging), and the CMS Medicare
Spending per Beneficiary measure as our main cost outcome. In Aim 2 we will use other measures of quality,
such as performance on mortality, or overall quality for specific conditions, and other measures of cost, such
as the CMS condition-specific risk-standardized payment measures developed by our team. In both aims, we
will explore the influence of provider, hospital and community factors on outcomes to determine the degree to
which they contribute to healthcare value and mediate patient factors. In Aims 1-2 we will use measures
already available in a number of datasets from CMS, the National Institutes of Health, the Census Bureau, the
American Hospital Association, the City Health Dashboard, the County Health Rankings and others. In Aim 3,
we will identify new predictors by directly surveying high and low value hospitals about specific practices that
are not available in existing datasets: for instance, aspects of quality infrastructure, Board and staff
engagement, electronic health record capabilities, data infrastructure, community coordination and others. We
will assess the association of those new predictors with the outcomes used in Aims 1 and 2. By the end of the
grant period, we expect to have developed a nuanced understanding of healthcare value that will enable
clinicians and policymakers to improve healthcare delivery for all patients.

Public health relevance
Narrative This grant will explore provider, hospital and community factors affecting the value (quality and cost) of inpatient care. A better understanding of what drives high value care will help hospitals across the country to more rapidly transform to a value-based healthcare system, improving healthcare quality and cost for all Americans.